From Research to Clinic: Addressing Ethical and Policy Challenges Facing the Gene Therapy Ecosystem

PROJECT SUMMARY
The U.S. Food and Drug Administration has approved gene therapies for several rare inherited diseases and
blood cancers, and hundreds of clinical trials are in progress testing the safety and effectiveness of gene
therapies for rare and ultra-rare disorders, various cancers, and complex neurological diseases. For patients
with rare and serious or debilitating disorders for whom existing treatment options are limited or do not work,
the approved gene therapies and the promise of others are encouraging signs that new treatment options are
emerging. Yet the translational gene therapy ecosystem faces several interrelated challenges: 1) obtaining
sufficient evidence of safety/effectiveness from clinical trials to justify FDA approval; 2) establishing cost and
payer coverage policies so patients have access to affordable treatments; and 3) generating sufficient safety
and effectiveness evidence of approved gene therapies when used in the clinical setting. The proposed project
will investigate how gene therapy challenges and associated ethical and policy issues that exist within the
translational gene therapy ecosystem are characterized and being addressed. We will 1) analyze documents
from federal and state policymakers (the FDA, the Centers for Medicare and Medicaid Services, relevant state
Medicaid agencies, the U.S. Congress) and organizations that play a role in agenda setting and influencing
public policy regarding the translational gene therapy ecosystem; 2) conduct a survey with physicians from four
therapeutic domains (hematology, infectious disease, neurology, oncology); 3) conduct in-depth interviews with
experts from five domains (translational gene therapy research and development; the FDA drug-approval/post-
marketing process; health policy/payer coverage; patient advocacy; bioethics/ELSI of genetics and genomics);
and 4) develop a) issue/policy briefs, b) recommendations for addressing gene therapy challenges and
associated ethical and policy issues, and c) recommendations for future normative and empirical analysis of
gene therapy challenges and associated ethical and policy issues. Innovative features of the proposed project
include being framed by the premise that gene therapy challenges are interrelated and co-exist within a
complex translational science ecosystem; examining how physicians, various experts, and policymakers are
grappling with gene therapy challenges; and applying a normative framework that draws on ideas and
concepts from bioethics and political science. The proposed project will synthesize the findings from the
document/policy analysis, survey, in-depth interviews, and normative analysis of gene therapy challenges and
associated ethical and policy issues to develop recommendations and issue/policy briefs that will 1) help
stakeholders in the translational gene therapy ecosystem in their deliberations and decision-making about
addressing gene therapy challenges and associated ethical and policy issues, and 2) identify ethical and policy
issues within the translational gene therapy ecosystem that warrant additional normative and empirical
investigation by various stakeholders.

Public health relevance
PROJECT NARRATIVE The translational gene therapy ecosystem faces several interrelated challenges: 1) obtaining sufficient evidence of safety/efficacy from clinical trials to justify regulatory approval of new gene therapies to treat inherited diseases, various cancers, and other complex diseases; 2) establishing cost and payer coverage policies so patients have access to affordable treatments; and 3) generating sufficient safety and effectiveness evidence of approved gene therapies when used in the clinical setting. The project will develop recommendations and issue/policy briefs to help stakeholders in the translational gene therapy ecosystem in their deliberations and decision-making about addressing gene therapy challenges and associated ethical and policy issues and to identify ethical and policy issues within the translational gene therapy ecosystem that warrant additional normative and empirical investigation by various stakeholders.